Project 5 - Bioavailability as a Central Concept in Determining Remediation Goals and Strategies for PCDD/F-Contaminated Superfund Sites

Due to their exceptionally low water solubilities, polychlorinated dibenzo-p-dioxins and -furans (PCDD/Fs) are
strongly and extensively bound to the solid particles of sediments and soils, especially charcoal-like pyrogenic
carbonaceous matter (PCM, [1]), amorphous organic matter (AOM), and clay minerals. The United States
Environmental Protection Agency (USEPA) conservatively assumes that 100% of soil-bound PCDD/Fs are
bioavailable to mammals, including humans [2], while measured bioavailabilities of PCDD/Fs in real soils are far
lower [3-13]. Real mammalian bioavailabilities are poorly understood, but we have recently advanced the science
of PCDD/F bioavailability from soils by relating it to the properties of individual particle types: We have shown
that PCDDs that are bound to AOM, clay minerals, or porous-silica particles are indeed 100% bioavailable
(relative to those in corn oil) [14-18]. In contrast, we showed that PCDDs bound to a special kind of PCM called
activated carbon (AC) had bioavailabilities of zero to mice [19, 20] and protected mammalian health. Our recent
work provides two hypotheses to inform risk assessment and remediation strategies for PCDD/F-contaminated
sites: 1) Low levels of PCM are ubiquitous in soils and sediments, so AC-like domains in PCM may be
responsible for lowering the mammalian bioavailabilities of PCDD/Fs in real soils, and 2) Our understanding of
soil particle types simplifies the complexity of soils enough that we can directly and mechanistically test whether
AC amendment of PCDD/F-contaminated soils has potential to be protective of human and ecosystem health by
minimizing mammalian bioavailability. Remediation using AC amendment was proposed long ago, because it is
far cheaper and less environmentally disruptive than removing contaminated soils to hazardous-waste landfills,
but regulators cannot adopt AC as a remedy because no one has shown that AC amendments are truly protective
of mammalian and human health. We propose a set of experiments designed to rigorously test the hypothesis
that PCDDs bound to AC amendments are no longer bioavailable to mammals, and thereby help USEPA and
state regulators critically assess this promising treatment for remediation of PCDD/F-contaminated Superfund
sites: We will track the full mass balance of PCDDs in soils after AC has been added, and then administer these
soils orally to mice and measure PCDD bioavailability and mass balance in the mice. For the first time, we will
directly measure the kinetics of PCDD accumulation in AC amendments and compare these with measured
kinetics of soil-PCDD mammalian bioavailability. This work will inform risk assessment by supplying data for six
practical criteria that EPA uses [21] to select Superfund remedies, including whether AC amendments are likely
to protect human and ecosystem health, the kinetics of their short-term bioavailability reduction, and the longer-
term stabilities of PCDD-AC complexes once they form. In sum, Project 5 will collaborate with the rest of the
Center to transform the experimental basis for regulatory decision-making about AC amendment as a potential
low-cost remediation treatment for PCDD/F-contaminated Superfund sites.

Public health relevance
PROJECT NARRATIVE Project 5 directly addresses NIEHS Superfund Mandate #4 for the development of “basic biological, chemical, and physical methods to reduce the amount and toxicity of hazardous substances” [22]. Project 5 will help USEPA understand whether activated carbon (AC) is an effective soil/sediment amendment to sequester PCDD/Fs in forms that eliminate their mammalian bioavailability and toxicity, and thus protect human and ecosystem health. Project 5 will test a cause-and-effect relationship for the rates at which AC can reduce or eliminate mammalian bioavailability by measuring a multi-year time series for a) the rates at which AC amendments accumulate PCDD/Fs and b) the mammalian bioavailabilities of PCDD/Fs from these same soils.